Promoting Muscle Regeneration through Adipose Signaling

PROJECT SUMMARY
Persistent muscle weakness and physical disability decrease quality of life for millions of Americans.
These physical limitations are linked with pathological accumulation of inter/intramuscular adipose tissue (IMAT)
across numerous populations and morbidities. This link combined with the resistance of IMAT accumulation to
standard diet and exercise remodeling cues points to IMAT as being a persistent and unaddressed clinical
problem, likely impeding rehabilitative efforts to maintain or increase muscle strength. The long-­term objective
of this research is to leverage our understanding of fat-­muscle cross-­talk to therapeutically modulate IMAT
paracrine signaling to promote muscle growth and regeneration. Recently, IMAT has been identified as a
specialized sub-­type of fat called beige fat, that can be stimulated to adopt features of brown fat, potentially
including the secretion of pro-­regenerative factors. It is the primary objective of this proposal to determine the
mechanisms of pro-­regenerative action of brown fat on muscle and whether this action can be mimicked by IMAT
stimulation. Our central hypothesis is that brown fat promotes muscle regeneration by enhancing myogenic
differentiation via paracrine secreted follistatin. To address our hypothesis, our approach will use our novel
system of mouse intermuscular fat transplant to model paracrine fat-­muscle cross-­talk. We will use this system
to control the timing and composition of brown fat signaling for mechanistic exploration of the cellular response
during muscle regeneration (aim 1) and the role of follistatin in mediating that response (aim 2). We will also
explore the therapeutic potential of mimicking brown fat paracrine signaling via stimulation in mouse and human
IMAT (aim 3). Altogether, these studies will broaden our understanding of the basic biology of brown fat signaling,
the nature of IMAT-­muscle cross-­talk and the therapeutic potential for stimulating IMAT and other depots of beige
fat to improve tissue physiology.

Public health relevance
PROJECT NARRATIVE Accumulation of fat within and between muscles is a hallmark of chronic muscle pathology and is thought to contribute to persistent muscle weakness and functional limitations. These experiments aim to define the nature of the interaction between fat and satellite cells (the cellular source for muscle growth and regeneration) with a specific focus on the role of fat phenotype. Knowledge gathered from this work will inform the development of adjuvant therapies targeting fat to improve muscle function and quality of life for the more than 1 million Americans seeking rehabilitative care for chronic muscle pathology.